Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY
The role of the Administrative Core is to help the OHSU Casey Eye Institute P30 Ophthalmology Core Facility
(1) provide support for NEI-funded investigators to help them achieve their current research goals, tap into new
experimental approaches and develop and successfully obtain ongoing funding; (2) take full advantage of the
broad, “bench to bedside” vision research infrastructure at OHSU by creating and strengthening collaborations
between basic, clinical and translational vision researchers; and (3) continue to support the academic
advancement of junior investigators as they pursue independent research careers. Four service cores will be
provided, three of which will be directed by co-PIs to provide a broader level of support and provide mid-career
investigators with experience in research administration. An Executive Committee consisting of overall PI John
Morrison and core PI’s will, with support from Casey administrators, establish allocation of resources, monitor
core access, productivity and budgeting and consider emerging research opportunities and technologies. This
committee will meet regularly twice a year but will maintain ongoing, informal communications. Executive
committee meetings will be attended by Brad Noren, Casey Grants Manager, and Nathan Lucia, Finance
Manager, to help provide input on grant regulatory and budgeting issues and avoid preventable lapses or cost
overruns. Support of junior investigators includes a Grants Mentorship Program instituted and run by Dr. Kate
Keller, co-PI of the Genetic Models of Ocular Disease and Biostatistics core. An Oversight Committee will consist
of Dr. Morrison, senior Casey leadership (Drs. Lauer, Chiang and Wilson) and two senior members of OHSU
leadership Mary Heinricher, PhD (Professor of Behavioral Neuroscience and OHSU Associate Dean for
Research) and Marc Freeman, PhD (Professor and Director of the Vollum Institute, OHSU). The main role of
this committee will be advisory, to review core activity, suggest improvements and, in particular, help identify
new research opportunities outside the OHSU vision research community. This will be accomplished by a yearly
core Oversight Committee meeting between this group and core PI’s that will begin with a review of
accomplishments for the previous year and allow free discussion and interchange of ideas. Service allocation
for users will be monitored by Dr. Morrison and will be kept equitable through electronic sign-up sheets for heavily
used equipment and through frequent direct communication. Feedback on core services will be sought through
direct communication, yearly on-line surveys, and feedback during twice-yearly OHSU Vision Research Meetings
(open to all core users). Scientific communication will be encouraged through regular dissemination of faculty
publication lists, monthly OHSU Vision Science seminars that will juxtapose clinical and basic research
presentations, and a new Clinical/Research Faculty Observership that will foster closer interactions between
clinicians and basic scientists to speed translation of basic science discoveries into clinical practice.